Engineering Dual-Targeted Nanoplatforms to Effectively Treat NSCLC.

ABSTRACT
Nanomedicine provides new opportunities to solve medical problems that were previously perceived as
unsolvable by clinicians. One such problem is drug resistance in Non-Small Cell Lung Cancer (NSCLC).
Attempts to overcome the resistance using small molecule inhibitors have failed to restore the drug sensitivity.
Alternative compensation survival pathways emerge to allow the regrowth of the tumor. To abate the tumor
growth, we need to suppress more than one survival pathway with minimal or no side effects. Nanoparticles
possess the ability to selectively and simultaneously arrest multiple survival pathways to control the growth of
the tumor. However, nanoparticles to co-knockdown multiple cross-linked survival pathways have not been
explored yet. We recently identified two targets AXL and FN14 and demonstrated that the cross-talk between
these markers is responsible for resistance in EGFR mutant NSCLC. Subsequently, we designed nanoparticles
to simultaneously co-knockdown both AXL and FN14 in the tumor, disrupted the cross-talk, and successfully
overcame drug resistance in murine models. The logical next step is to validate the findings in clinically relevant
animal models and patient samples. It is equally important to optimize the size of nanoparticles further to
maximize deep tumor delivery with favorable in vivo characteristics. Therefore, in this proposal, we will
synthesize different sizes of NP, understand their ability to penetrate deep inside the tumor to fully restore drug
sensitivity for a long-lasting therapeutic response. We will use patient tissues, patient-derived organoids, drug-
resistant cell lines, orthotopic animal models, and patient-derived xenografts to establish the efficacy of the
nanoplatform. The data will validate our new nanoparticle platform, as a promising strategy to combat drug
resistance in NSCLC and catalyze clinical trials in the future.

Public health relevance
This R01 application will design and develop a targeted nanoparticle that possesses the ability to selectively knockdown multiple proteins in the lung cancer cells that are responsible for drug resistance and thereby sensitize the solid tumors to drug therapy. The academic institutions (MU and UCSF (subcontract)) will work together to assess the nanoparticles in clinically relevant patient derived organoids and patient derived mouse xenografts.